The Synthesis of Bioactive Natural Products as a Driving Force for Discovery in Organic Chemistry

Abstract
Not applicable for Diversity Supplement

Public health relevance
Narrative Not applicable for Diversity Supplement